Continuing the Conversation: A Multi-site RCT Using Narrative Communication to Support Hypertension Self-Management among African-American Veterans

Background: In response to the VA HSR&D Healthcare Equity and Health Disparities major priority domain, we
propose Continuing the Conversation, an RCT testing use of narrative communication to support and sustain
hypertension (HTN) self-management among African-American Veterans. Compared to other racial and ethnic groups,
non-Hispanic African Americans have an earlier onset and higher prevalence of HTN as well as a disproportionately
higher risk of complications, leading to higher rates of cardiovascular morbidity and mortality. In previous work, we used
storytelling in African Americans outside the VA, yielding significant improvements in blood pressure. We translated
these findings to the VA, developing and testing video-recorded Veteran narratives which we showed to African-
American Veterans. We demonstrated significant differences in intention to change HTN management behavior
immediately after video viewing; however, effects on blood pressure were not sustained, and six-month outcomes
revealed only modest benefit over control (p = 0.06). Our findings highlight the need for longitudinal support to sustain
the storytelling effect. Our proposed study provides longitudinal support via text messages, incorporating content from
the participant’s chosen peer narrative as a means of sustaining motivation and engagement in HTN self-management.
Innovativeness: Despite the proliferation of texting studies in the medical literature, very few have been rigorous
randomized trials. African-Americans have been under-represented in technology-assisted interventions, and trials using
texting for HTN self-management in Veterans have not been conducted. Our proposal, “Continuing the Conversation,” is
a novel integration of peer narrative communication into technology. While use of an informatics tools (texting) as a
channel to support self-management is not novel per se, the extension of a narrative via longitudinal texting is an
innovative mechanism for supporting and sustaining HTN self-management behaviors. Our Specific aims include:
Aim 1. Refine and Pilot the Continuing the Conversation (CTC) intervention. Previously, we created video-recorded
stories told by African-American Veterans with HTN, describing their self-management strategies. We will refine CTC by
adapting content from these videos to create narrative-aligned texts and we will pilot CTC.
Aim 2. Test CTC by conducting a randomized controlled trial. CTC ‘begins the conversation’ by showing Veteran Story
videos to participants, then inviting participants to select a preferred narrative. We then ‘continue the conversation,’
offering longitudinal support via 6 months of narrative-aligned text messages. Messages cover key HTN content,
providing education, reminders and weekly assessments, and include quotations derived from the chosen narrative.
Control participants receive weekly assessment texts addressing the same key HTN self-management behaviors.
Aim 3. Evaluate CTC effectiveness, and mediating factors, and conduct a cost analysis. We hypothesize that, for the CTC
Intervention group as compared to the control: (H1)the difference in blood pressure from baseline to 6 months (primary
outcome) will favor CTC intervention compared with the change in control. (H2): Self-efficacy and HTN management
behaviors during 6-month follow-up will be greater for those in the CTC intervention group than control.
Methods: In a randomized controlled trial, 600 African-American Veterans with poorly controlled HTN will be recruited
from 2 VA healthcare sites with known disparities in HTN control. We will use within-site randomization (CTC vs.
Control). Outcomes will include blood pressure, self-efficacy and HTN management behaviors. Longitudinal texts are
designed to bring the storyteller back into the Veteran’s everyday life, reminding and reinforcing as our Veterans engage
in the numerous daily decisions that will impact their blood pressure and their lives. Incorporating peer content into text
messages in this way is highly innovative and offers a promising approach to supporting our Veterans.
Next Steps: During and following this trial, we will provide materials to our operational partner, the Office of Connected
Care (OCC), for presentations to National Leadership Council including to VISN Directors and also explore other avenues
for dissemination. We will work with OCC to create an Electronic Health Record-based referral tool to encourage clinical
teams to enroll patients and will explore mechanisms by which Veterans can initiate the request for enrollment.

Public health relevance
We propose a randomized controlled trial aimed at improving hypertension self-management and lowering blood pressure (BP) in African-American Veterans. In previous HSR&D-funded work, we created video-recorded stories told by African-American Veterans with hypertension, in which Veterans shared strategies for effective self-management. In this study, we `begin the conversation' by showing these videos to Veteran participants, inviting them to select the peer narrative that is most compelling. We then `continue the conversation', offering longitudinal support via 6 months of narrative-aligned text messages. Texts will cover key subject areas, providing education, reminders and periodic assessments, and include quotations derived from and aligned with transcripts from the chosen narrative. We will measure the intervention's impact on BP, self-efficacy and self-management behaviors, and conduct a cost analysis. 1